Functionally Assessing Transcriptional Enhancers In Vivo

Transcriptional enhancers are the most common class of noncoding regulatory sequence in the human genome,
where hundreds of thousands of enhancers far outnumber our ~20,000 protein-coding genes. There is now
irrefutable evidence from experimental studies for critical roles of enhancers in human disease, suggesting that
a significant proportion of the thousands of non-coding GWAS findings is due to altered enhancer functions. At
the dawn of the personalized genome sequencing era, with nearly 100,000 whole genomes sequenced
by NHGRI’s Genome Sequencing Program alone, determining causal links between enhancers and
human disease has become a Grand Challenge in biology. Over the past three funding cycles of this R01,
our group spearheaded the combined use of comparative genomics, chromatin profiling, and high-throughput
mouse engineering to create transformative approaches and unique resources for enhancer discovery and
characterization. Through our VISTA Enhancer Browser and a large series of associated experimental studies,
we have identified ~300,000 putative enhancers from mouse tissues, performed ~3,000 transgenic mouse
assays to determine in vivo enhancer activities, deleted >50 enhancers from the mouse genome, assisted
hundreds of outside investigators, and provided data access to a global community of >2,000 unique VISTA
users/month. Despite this substantial progress, significant remaining questions preclude the interpretation of
genetic variants affecting enhancers, impeding efforts to elucidate the pathophysiological consequences of
enhancer mutations. Specific barriers include a lack of understanding for how variants alter the activity
of any given enhancer, and the lack of cellular resolution and thus cell type specificity information for
most in vivo enhancers identified to date. In this competitive renewal, we propose to: (1) Generate a large
panel of 4,500 human mutation alleles of validated VISTA enhancers and determine their impact on function in
vivo through a novel, high-throughput, site-specific transgene integration system in mice, (2) Determine the
expression and phenotypic impact of the most severe mutations identified in Aim 1 through 100 CRISPR
knockins of human wild-type and mutant enhancers to the orthologous mouse loci, (3) Perform single-cell RNA
sequencing from mouse tissues marked by active enhancers in purpose-engineered reporter mice to determine
the in vivo cell type specificities of 500 validated VISTA enhancers, and (4) Provide continued community access
to genomic enhancer resources including high-throughput transgenic capabilities to characterize 500 enhancers
in vivo. Through these studies, we expect to gain significant insight into the role of enhancers in mammalian
biology, revealing the impact of enhancer mutation on gene expression and downstream phenotypes, and the
cell type specificity of enhancer activity in animals. With the now realized growth of clinical whole-genome
sequencing, this work will be vital to understanding and predicting the consequences of sequence variation in
noncoding DNA in human quantitative traits and disease.

Public health relevance
In addition to genes, human DNA contains tens of thousands of so-called enhancers, which represent switches that turn genes on and off in different cell types and tissues. While these enhancers are important for normal human development and are expected to play a role in many major human diseases, they have been difficult to study in the past. We propose to use a panel of new cutting-edge approaches to study the general importance of enhancers and how their mutation may lead to human disease.